2022 Vascular Discovery: From Genes to Medicine

ABSTRACT
The Councils on Arteriosclerosis, Thrombosis, and Vascular Biology (ATVB) and Peripheral Vascular
Disease (PVD) of the American Heart Association (AHA) hold an annual Spring Meeting “Vascular Discovery:
From Genes to Medicine” the most recent of which (in-person) was held in Chicago, IL, May 5-7, 2019. The
meeting was a resounding success with 885 registrants. Five hundred and sixty abstracts were submitted to
ATVB 2019, well above the typical ~400 abstracts that had been submitted in earlier years. These
encouraging statistics provide tangible evidence of the broad interest and commitment of the scientific
community in the topic areas of ATVB, PVD and vascular medicine and the overwhelming enthusiasm for the
format and atmosphere of this meeting. Basic scientists, translational researchers and clinicians, seasoned
investigators and early career scientists, enjoy coming to this AHA Spring meeting. The next ATVB/PVD
conference is scheduled to be held May 20-22, 2022 at the Hilton in New Orleans, Louisiana. As with
previous applications, this proposal specifically requests support for our Young Investigator Travel Awards.
Knowing that early stage investigators are the future of our scientific progress, a major emphasis of our
annual conference is to encourage the active involvement of the younger cohort of investigators in the ATVB
and PVD Councils of the AHA. Young Investigator Travel Awards have been supported by the NIH/NHLBI for
15 years. These awards are an integral part of our strategy to recruit, retain and actively engage young
investigators in the fields of arteriosclerosis, thrombosis, vascular biology and vascular medicine research
that are of major importance to the NIH-NHLBI and the health of the U.S. population.

Public health relevance
This application seeks support for Travel Awards for Young Investigators to attend the 2022 Vascular Discovery: From Genes to Medicine Scientific Sessions. This conference is organized by the Arteriosclerosis, Thrombosis, and Vascular Biology (ATVB) and Peripheral Vascular Disease (PVD) Councils of the American Heart Association. The Vascular Discovery conference provides unique opportunities for early stage investigators to meet peers, present their work, and interact with senior colleagues across distinct disciplines that have an interest in cardiovascular disease as a unifying theme.